uNDERSTANDING AND TARGETING SENESCENCE IN CLONAL HEMATOPOIESIS

Clonal hematopoiesis (CH) is characterized by the presence of hematopoietic cells carrying one or more somatic
mutations in the absence of overt hematological disease. The prevalence of CH rises with age and has been
associated with increased mortality and a higher risk of progression to hematological cancers, as well as agerelated conditions such as cardiovascular and pulmonary events and liver disease. However, the mechanisms underlying the promotion of CH and its connection to age-related sequelae are not fully understood. A prominent
feature of aging is the accumulation of senescent cells. Cellular senescence represents a stress response
program marked by a halt in proliferation and the release of a proinflammatory Senescence-Associated
Secretory Phenotype (SASP). Under normal circumstances, the SASP attracts immune cells, targeting
senescent cells and restoring tissue homeostasis. However, increased tissue damage and declining immune
function impede this clearance during aging, resulting in a chronic pro-inflammatory milieu. Evidence suggests
chronic inflammation promotes CH and alters the balance between quiescence, self-renewal, and lineage
commitment in hematopoietic stem and progenitor cells (HSPCs). Preliminary data from our research indicates
that CH-mutant clones heavily rely on proinflammatory cytokines, and in aged animal models, they aggregate
near senescent cells. The goal of my KOO postdoctoral work is to elucidate the role of cellular senescence in the
progression of CH. I aim to explore the interactions between senescent cells and CH-mutant clones and identify
key signaling molecules that could be potential biomarkers for disease progression in aging. Additionally, I will
utilize uPAR-CAR T cells to eliminate senescent cells and study how this affects CH expansion, thus interrogating
the therapeutic potential of targeting senescence to prevent high-risk CH. In conclusion, completing my proposed
work will yield new insights into the age-driven progression of CH, as well as the development of novel
biomarkers and therapeutic strategies from a senolytic angle.

Public health relevance
Clonal hematopoiesis (CH) is characterized by the presence of hematopoietic cells with somatic mutations in otherwise healthy individuals, and its prevalence increases with age and is associated with elevated mortality rates, as well as a higher susceptibility to hematological cancers and age-related diseases. While the precise link between CH and aging remains incompletely understood, I hypothesize, building upon preliminary data, that the accumulation of senescent cells due to aging may significantly exacerbate a pro-inflammatory environment that facilitates CH. My KOO postdoctoral research aims to elucidate the contribution of senescent cells to CH progression and investigate the therapeutic potential of targeting senescent cells to mitigate the expansion of high-risk CH in the aging population.